Intra-articular corticosteroid injections for symptomatic osteoarthritis: The effects of injection dose, frequency, and timing on safety

PROJECT SUMMARY / ABSTRACT
Osteoarthritis (OA) is the most common type of arthritis and a frequent cause of pain and disability.
Osteoarthritis annually affects ~595 million adults globally, with anticipated rises in incidence due to aging of
the population. Treatment guidelines for symptomatic OA of the knee, hip, and shoulder recommend non-
surgical intervention as first-line care to delay or avoid joint replacement surgery. Intra-articular corticosteroid
(IACS) injections are routine outpatient procedures for OA to reduce pain, decrease reliance on oral analgesic
medications, and improve function and quality of life. Patients often report weeks to months of benefit and
often receive several injections per year. Yet, uncertainty remains about the safety of single and repeated
IACS injections. Systemic corticosteroids (often delivered orally or intravenously) are associated with serious
adverse effects, including impaired immune response, cardiovascular disease, and accelerated osteoporosis.
These risks are tolerated for corticosteroid treatment of life-threatening conditions, but risk tolerances are
typically lower for elective procedures such as IACS injection. However, even though IACS injections result in
systemic corticosteroid absorption, there is a lack of rigorous evidence about their safety. Most evidence
comes from randomized trials that exclude high-risk patients and are limited by small sample sizes and short
follow-up. Small clinical studies of the effects of IACS injections have demonstrated elevations in blood
pressure and blood glucose, reductions in bone density, and increased risk of infection, but larger studies are
needed. There is no evidence-based consensus on the maximum safe exposure level with respect to
modifiable IACS injection factors including dose, timing, or frequency. Consequently, treatment guidelines for
OA are inadequate and fail to offer best practice recommendations regarding maximum safe doses, maximum
number of injections per year, minimum time interval between injections, or considerations for high-risk
patients. Overall, the lack of evidence may lead to potential unnecessary harm. Rigorous evidence is needed
to guide optimal pain management strategies to treat OA and determine the maximum safe exposure level of
IACS injections. To fill this knowledge gap, we propose a large, non-experimental study to examine the
utilization and safety of IACS injections. We will use Medicare claims data with ~17.4 million older adult
recipients of IACS injections for the treatment of symptomatic OA of the knee, hip, or shoulder. We will
characterize patterns of use of IACS injections and examine whether more frequent, closely spaced, and
higher dose exposure to IACS injections are associated with increased risk of an array of individual adverse
events (e.g., infections, cardiovascular events, osteoporotic fractures). We will perform subgroup analyses in
medically complex patients. This large study will generate evidence to address critical gaps in knowledge
about how to optimize the safety of IACS injections to treat symptomatic OA. Results will inform shared clinical
decision-making, prevent harms, and promote continued independence among older adults in the community.

Public health relevance
PROJECT NARRATIVE Intra-articular corticosteroid (IACS) injections are commonly administered for the treatment of symptomatic osteoarthritis of the knee, hip, and shoulder, however treatment guidelines fail to offer best practice recommendations about modifiable injection factors or special considerations for complex patients who may be at higher risk of complications. Our proposed study will evaluate the maximum safe exposure level with respect to modifiable IACS injection factors including dose, timing (interval between injections), and frequency (total number of injections per year or over years), in the overall population and potential high-risk subgroups. The ultimate goal will be to help clinicians make informed decisions about how to minimize safety risks for patients who require repeated IACS injections to manage symptomatic osteoarthritis.